CTN - Evaluation of SeMaglutide as an Adjunct to buprenorphine treatment for the treatment of opioid use disorder: A pragmatic Randomized placebo-controlled Trial (SMART)

Evaluation of SeMaglutide as an Adjunct to buprenorphine treatment for the treatment of opioid use
disorder: A pragmatic Randomized placebo-controlled Trial (SMART)
ABSTRACT/PROJECT SUMMARY
The opioid overdose epidemic is a public health crisis that shows little signs of abating. In the 12-month
period ending in February 2022, over 100,000 people in the U.S. died of an overdose and more than
75,000 involved opioids. Buprenorphine as a treatment for Opioid Use Disorder (OUD) is highly eﬀective
in decreasing overdose deaths. but retention is challenging. However, BUP as a mono-therapy may be
insuﬃcient for eliminating illicit opioid use, craving, and stimulant co-use and BUP treatment retention is
problematic. Stimulant use by individuals with OUD has been increasing. Importantly, BUP retention may
be particularly challenging for individuals who use stimulants, and stimulant users may be more likely to
continue illicit opioid use. Thus, stimulant use may be an important therapeutic target for individuals
enrolled in BUP. BUP treatment retention is strongly associated with decreased mortality, with the risk of
overdose increasing dramatically after discontinuing BUP. Semaglutide, a glucagon-like peptide-1 (GLP-1)
analog, may have a beneﬁcial treatment eﬀect on illicit opioid use, craving, and stimulant co-use.
Semaglutide, which was approved for treating type 2 diabetes in 2017 (Ozempic®) and for weight
management in 2021 (Wegovy®), has superior receptor binding aﬃnity and a longer duration of action
relative to older GLP-1 analogs. Semaglutide also holds promise as a treatment for stimulant use
disorders.
The present study is a multi-site, randomized placebo controlled pragmatic trial with the primary
objective of evaluating the impact of semaglutide, relative to placebo, as an adjunct to BUP on substance
use outcomes with illicit opioid use as the primary outcome. Evaluating the eﬀect of semaglutide,
relative to placebo, as an adjunct to BUP on BUP retention is a secondary objective. While it is expected
that semaglutide will be more eﬀective as an adjunct than as a mono-therapy for OUD, the BUP dropout
that will naturally occur during the trial provides the opportunity to explore the feasibility of, and collect
some eﬃcacy data on, the provision of semaglutide, relative to placebo, in individuals discontinuing BUP.
The exploratory aim is to compare substance use outcomes and opioid-related overdoses for the
semaglutide and placebo groups in individuals discontinuing BUP.

Public health relevance
Evaluation of SeMaglutide as an Adjunct to buprenorphine treatment for the treatment of opioid use disorder: A pragmatic Randomized placebo-controlled Trial (SMART) PROJECT NARRATIVE The present study is a multi-site, randomized placebo controlled pragmatic trial with the primary objective of evaluating the impact of semaglutide, relative to placebo, as an adjunct to BUP on substance use outcomes with illicit opioid use and on retention in treatment. While it is expected that semaglutide will be more effective as an adjunct than as a mono-therapy for OUD, the BUP dropout that will naturally occur during the trial provides the opportunity to explore the feasibility of, and collect some efficacy data on, the provision of semaglutide, relative to placebo, in individuals discontinuing BUP. The exploratory aim is to compare substance use outcomes and opioid-related overdoses for the semaglutide and placebo groups in individuals discontinuing BUP.